Development of an oxygen delivery biotherapeutic for the preservation of myocardial function during pediatric cardiopulmonary bypass

1. PROJECT SUMMARY/ABSTRACT
Omniox is developing a unique oxygen delivery protein, OMX, as a treatment to preserve myocardial
and peripheral organ function and significantly reduce morbidity after neonatal cardiopulmonary
bypass (CPB) during surgical correction of congenital heart disease (CHD). Of the ~40,000 children born
annually with CHD, ~10,000 require urgent surgery to repair heart defects1, 2. Up to 60% of infants who
undergo CPB will experience post-operative complications that can result in peripheral organ dysfunction and
long-term neurological deficits3-15.
A critical driver of the myocardial and peripheral organ tissue damage is oxygen deprivation, or hypoxia3-15.
However, there are no current or promising therapeutic approaches that target hypoxia during CPB surgery to
stem or alleviate its damaging downstream effects. Omniox’s lead therapeutic candidate, OMX, is designed
to oxygenate hypoxic tissues. Supported by preliminary data from our Phase I/II Fast-Track SBIR and
generated with our collaborators, neonatal and pediatric care intensivists Drs. Fineman and Maltepe at the
University of California, San Francisco (UCSF), OMX has the potential to address a high unmet need of
preserving myocardial function and decreasing morbidity associated with neonatal CPB surgery.
The objective of this SBIR Phase IIB proposal is to advance development of OMX as a novel biologic for the
treatment of neonates undergoing CPB by demonstrating its therapeutic utility in oxygenating hypoxic tissue
and preserving myocardial and peripheral organ function. We propose to confirm that a more stable variant of
OMX preserves myocardial and peripheral organ function after CPB and identify the optimal dose regimen for
OMX efficacy (Aims 1 and 2), adapt and optimize a scalable production process suitable for transfer to a GMP
(Good Manufacturing Practice) contract development and manufacturing organization (CDMO), including
process and analytical development (Aim 3), and prepare and submit an IND for a Phase 1 clinical trial in
neonates (Aim 4). Pending good safety and efficacy data in neonatal and pediatric patients undergoing CPB,
Omniox plans to expand OMX use to other pediatric indications in which hypoxia drives disease pathology
such as persistent pulmonary hypertension in neonates16, 17 and birth asphyxia18-22.

Public health relevance
PROJECT NARRATIVE Omniox is developing a novel oxygen carrier protein, OMX, to preserve heart function during open-heart surgery that requires cardiopulmonary bypass (CPB). Approximately 10,000 children in the US are born every year with congenital heart defects that necessitate urgent open-heart surgery with CPB to correct the defect. However, while the patient is on CPB, the heart and other major organs are exposed to a lack of oxygen (hypoxia). The hypoxic environment drives a vicious cycle in which the heart tissue is damaged, negatively altering blood flow and reducing oxygen levels, and depriving all organ systems even further of oxygen. This cycle can result in a spectrum of post-operative complications, including reduced heart function, long-term neurological deficits, and kidney failure. This SBIR Phase IIB project will focus on testing OMX during bypass surgery in a clinically-relevant large animal model of congenital heart defect to validate OMX as a therapeutic to preserve heart and peripheral organ function in neonates requiring corrective heart surgery.